ESTABLISHING THE ROLE OF BONE MARROW STROMAL ANTIGEN 2 IN HEMATOPOIETIC STEM CELL NICHE INTERACTIONS AND ACTIVATION

Abstract
Interferon gamma (IFNγ) is a pro-inflammatory cytokine that is upregulated during chronic infections and leads
to activation, differentiation, and eventual loss of hematopoietic stem cells (HSCs). We previously showed that
these effects may contribute to bone marrow (BM) insufficiency and cytopenias during chronic infection.1 Despite
its clinical significance, the mechanism by which IFNγ activates and depletes HSCs is unknown. Since HSCs
are heavily influenced by their interaction with the BM microenvironment2, we previously studied the impact of
IFNγ on HSC-niche interactions. Our preliminary data show that HSCs activated by IFNγ re-localize in the BM
away from quiescent-promoting CXCL12-abundant reticular (CAR) cells. We used transcriptomic analysis to
identify Bone Marrow Stromal Antigen 2 (BST2) as the only surface protein upregulated upon IFNγ stimulation
during the early stages of HSC migration. Our work to date shows that BST2-deficient mice have more HSCs
present in the BM, their HSCs are less proliferative than wild type (WT) HSCs, and BST2 KO HSCs do not re-
localize from CAR cells during IFNγ induction suggesting that BST2 could play a role in regulating activation.
Previous reports have suggested that BST2 could serve as an adhesion protein to facilitate migration in other
cell types, and we suspect that it may perform a similar function in HSCs. The overarching goal of this proposal
is to elucidate the role of BST2 in HSC activation by determining BST2-protein interactions and its impact on
HSC interactions within the niche. We hypothesize that increased expression of BST2 promotes HSC
activation during inflammatory stress by facilitating binding to alternative niche cell types. To test the
hypothesis, in Aim 1, we will establish BST2-surface protein interactions in HSCs using cross-linking aided
affinity purification mass spectrometry. We will further determine whether blocking these interactions will affect
HSC activation by measuring HSC numbers, proliferation and cell cycle status. In Aim 2, we will identify the BM
niche cells that facilitate BST2-mediated HSC activation by performing intravital imaging using a variety of BM
reporter mice to identify the spatial location of HSCs relative to the other niche cells. Direct interaction between
BST2-positive HSCs and niche cells will also be tested. Collectively, the experiments proposed here aim to
expand our understanding of the mechanism by which BST2 alters HSC-niche interactions. Elucidating how
HSCs become activated during IFNγ stimulation will provide insight into the mechanisms by which inflammation
drives HSC exhaustion and will potentially lead to novel therapeutic strategies for bone marrow failure syndromes
associated with excessive inflammation.

Public health relevance
Project Narrative The inflammatory cytokine interferon-gamma (IFNγ) contributes to bone marrow failure syndromes by activating hematopoietic stem cells (HSCs) and impairing their self-renewal. Our preliminary data suggest that bone marrow stromal antigen 2 (BST2), which is induced by IFNγ, could mediate HSC loss by promoting re-localization of HSCs within the bone marrow niche. This proposal aims to elucidate the role of BST2 in HSC-niche interactions during IFNγ activation, with the overall goal of uncovering novel therapeutic targets to treat bone marrow failure in patients with chronic infection or inflammation.